Roles of immunity to the microbiota in peripheral nerve regeneration and pain sensation.

Project Summary/Abstract
Research: Peripheral neuropathy, a condition involving damage to the peripheral nervous system (PNS), affects more than
20 million people in the United States. Protection and restoration of PNS is of particular relevance upon barrier tissue injury,
a leading cause of PNS damage, to promote somatosensory recovery and regulate pain. Of note, injury and repair at the
barrier tissues occur in the context of commensal microbiota-specific T cell responses. Indeed, reactive commensal-specific
T cells promote wound healing and sensory neuron regeneration upon injury. However, how commensal-specific T cells
contribute to PNS restoration upon injury, and what the long-term consequences of the T cell response are on pain sensation,
represent a fundamental yet unexplored area of research. My preliminary data show that Interleukin 17A (IL-17A) produced
by commensal-specific T cells signals to sensory neurons via the IL-17 receptor A (IL-17RA), the transcription of which is
upregulated in injured neurons, promoting sensory nerve regeneration. However, neither the upstream factors controlling
IL-17RA upregulation nor the downstream signaling and transcriptomic regulation has been formally studied in injured
neurons. My overarching hypothesis is that commensal-specific T cells control PNS regeneration in the skin upon injury
and regulate long-term pain sensation via IL-17A/IL-17RA signaling. To assess my hypothesis and the potential
neurotrophic function of IL-17A, I will study how IL-17A enhances PNS regeneration (Aim 1 and 2), and the long-term
consequences on pain sensation (Aim 3) in three complementary mouse models of nerve injury: (i) ear skin punch, for
mechanistic insights into nerve regeneration; (ii) sciatic nerve transection (SNT), for therapeutic evaluation of IL-17A; and
(iii) footpad skin injury, which allows the use of standard tests to asses pain sensation. Career goals: My long-term goal is
to become an independent investigator at an academic institution, where I will explore the communication between the
immune and peripheral nervous systems at barrier sites in response to the microbiota, ultimately translating my findings
into novel therapies to treat neuroimmune-related disabilities. I also aspire to become an inspirational mentor and teacher.
Career development: I will meet weekly with Dr. Belkaid and discuss my progress with collaborators every 6 months for
the duration of the award. Before the K award, I will improve my bioinformatics skills (advance bioinformatics courses),
attend at least to 2 international conferences (oral presentation), attend NIH training courses (teaching and mentoring
workshops and laboratory management). Environment: The NIH Intramural Research Program has more than 1,200 PIs
conducting basic, translational, and clinical research. It is a unique environment with resources for the career development
(including microbiome, pain study center and immunology core facilities, and frequent seminars and opportunities to engage
with colleagues/mentors). Prior to the K award, I will work in the laboratory of Dr. Belkaid, which is a BSL-2 research
space and is adequately equipped to conduct the proposed experiments. Furthermore, I have assembled a mentoring team
that will complement my expertise in neuroimmunology and closely oversee my training in microscopy (Dr. Ron Germain)
and somatosensory neurons (Dr. Alexander Chesler and Dr. Claire le Pichon).

Public health relevance
Project Narrative Peripheral neuropathy is a major health concern, demanding novel approaches for the restoration of injured nerves. Protection and restoration of peripheral neuron system upon barrier tissue injury happen in the context of the immune response to the microbiota. This proposal will study how the microbiota-specific immune response promotes peripheral nerve regeneration, with the goal to identify novel therapeutic approaches to promote somatosensory recovery and mitigate neuropathies and chronic pain.